Selenocyanate as a novel treatment of cystic fibrosis lung disease

PROJECT SUMMARY
The mechanism(s) by which infection-mediated inflammatory processes drive progressive lung disease remains
elusive. Novel preliminary data supports an evolutionary selective metabolism pathway that may explain how the
lung defends against pathogen colonization without harming itself in the process. We have discovered that
mammalian selenocysteine containing thioredoxin reductase (Sec-TrxR), an enzyme found in the lung, can
detoxify the haloperoxidase produced hypothiocyanate (HOSCN) and recycle it back to -SCN. We hypothesize
that cysteine-containing thioredoxin reductase (Cys-TrxR) from prokaryotic bacteria such as E. coli and P.
aeruginosa cannot detoxify HOSCN due to differences in enzyme structure, especially the lack of a C-terminal
selenocysteine residue found only in higher eukaryotes. Cystic fibrosis (CF) is due to mutations in the cystic
fibrosis transmembrane conductance regulator (cftr) gene that encodes for an apical membrane anion
transporter protein that transports a number of anion species including -SCN. CF subjects have chronic lung
infections that contribute to morbidity and mortality associated with this genetic disease. The CFTR protein
transports -SCN into the airway surface fluid and we hypothesize that this is a critical feature of the aberrant host
defense associated with CF lung disease. -SCN can directly react with HOCl producing HOSCN which can be
metabolized by the host but not the pathogen. We provide preliminary data supporting the ability of mammalian
Sec-TrxR to detoxify HOSCN and the inability of prokaryotic Cys-TrxR to detoxify HOSCN. We have published
in vitro and in vivo data on the importance of CFTR in maintaining airway fluid -SCN levels and preliminary
studies that inhaled -SCN dramatically improves morbidity and decreases lung inflammation in a P. aeruginosa
lung infection mouse models. Novel data is presented that a SCN analog, selenocyanate (–SeCN), is more potent
antimicrobial than SCN, but shares all the selective detoxification benefits of -SCN. The working hypothesis is
that in CF the lung cannot use -SCN optimally resulting in haloperoxidases make more hypochlorite (HOCl) which
is not selectively detoxified and produces more lung damage and inflammation. Specific aim 1 will determine
the chemical mechanism by which Sec-containing TrxR resists inactivation by HOSCN/HOSeCN oxidation and
Cys-containing TrxR are inactivated by HOSCN/HOSeCN. Specific aim 2 will examine CFTR’s and Sec-TrxR’s
role in the importance of –SCN/HOSCN -mediated lung host defense against bacterial infection. Specific aim 3
Examine -SeCN as a potential therapy for treatment of lung inflammation and infection using wild type and CFTR
KO and -ENaC Tg mouse models. The major innovations in this proposal are: 1) our novel discovery of selective
detoxification of HOSCN/HOSeCN by mammalian Sec-TrxR that allows the lung to defend against pathogens
without harming self; 2) novel targeting of prokaryotic Cys-TrxR by HOSCN/HOSeCN; 3) –SCN/-SeCN may
improve neutrophil and macrophage host defense functions; 4) improvement in lung infection models with
nebulized -SeCN; and 5) proof of principle studies to bring -SeCN therapy into the clinic.

Public health relevance
PROJECT NARRATIVE A novel evolutionary selective metabolism pathway is proposed showing how the lung defends against pathogen colonization without harming itself in the process. Disturbance in this process contributes to two hallmarks of infectious airway disease: 1) impaired ability to clear bacteria; and 2) impaired resolution of lung inflammation. This proposal will test whether a thiocyanate analog selenocyanate will improve resolution of lung inflammation, improve bacterial clearance, and lung function.